Genetic Regulation of Cochlear Duct Patterning and Prosensory Formation

PROJECT SUMMARY
Sensorineural deafness is typically caused by the irreversible loss of the inner ear hair cells (HCs). Currently,
there is no treatment available to reverse the loss of HCs. Recent advance in regenerative medicine offers
promise in treating sensorineural deafness through HC regeneration. Elucidating the molecular mechanism
underlying the formation of the inner ear HCs will aid our effort to regenerate HCs and restore hearing. During
early cochlear development, the partially overlapping expression of GATA3, ISL1, ISL2, and their negative
regulators, LMO3 and LMO4, suggests a novel model for the regulation of cochlear duct patterning and
sensory formation, in which the expression of GATA3, ISL1, and ISL2 makes the ventral cochlear epithelium
competent to form the sensory region and the expression LMO3 and LMO4 suppresses the transcriptional
activity of ISL1, ISL2, and GATA3 in all but the presumptive prosensory domain. Consistent with this model, we
have shown that targeted deletion of Lmo4 leads to the formation of an ectopic organ of Corti completed with
inner and outer HCs and supporting cells in the presumptive external sulcus. Loss of Lmo4 also results in a
broader expression domain of CDKN1B, a cyclin-dependent kinase inhibitor and an early marker of the
developing sensory organ. Conversely, deletion of Gata3 impairs the formation of the sensory domain and
leads to the loss of CDKN1B expression. Interestingly, our preliminary study showed that while loss of Isl1 or
Isl2 alone has no significant effect on the formation of prosensory domain, compound Isl1/Isl2-null mutation
abolishes the CDKN1B-expressing prosensory domain, suggesting that Isl1 and Isl2 could function redundantly
in specifying prosensory region. To further understand the role and mechanism of ISL1 and ISL2 in
determining the prosensory domain in the cochlea, we will knock out Isl2 and Isl1/Isl2 specifically in the inner
ear and assess the effect on cochlear duct patterning and sensory formation. In addition, we will knock out
Lmo3 and Lmo4 specifically in the inner ear and investigate their function during cochlear duct patterning and
sensory formation. To understanding the underlying functional mechanism, we will use RNA-Seq, snRNA-
Seq/snATAC-Seq, and CUT&Tag technologies to identify candidate genes that are directly controlled by ISL1,
ISL2, and GATA3 in the ventral cochlear epithelium. Together, this study will provide significant information
about the molecular events underlying sensorineural deafness, accelerate the discovery of novel sensorineural
deafness genes, and aid our effort to regenerate inner ear HCs to restore hearing. Additionally, elucidating the
novel interaction among the LIM-HD, LMO, and GATA proteins will advance our knowledge of their roles in the
development and pathogenesis of the inner ear and other tissues.

Public health relevance
PROJECT NARRATIVE Degeneration of the inner ear hair cells is the major cause for hearing loss. De novo regeneration of the hair cells presents promising approaches to treat hearing loss. The proposed studies are aiming at identifying genes and genetic processes essential for the early development of mammalian cochlea and the formation of the organ of Corti and will provide the foundation for future treatment for hearing loss.